DEVELOP TRAINING IN THE PRINCIPLES, METHODS, AND ETHICS OF CLINICAL RESEARCH UNDER THE CLINICAL RESEARCH REPRODUCTIVE SCIENTIST TRAINING (CREST)

This project is for the delivery of a 20 week web-based educational program in clinical research design and biostatisitics specially designed for reproductive medicine trainees. Consulting with CREST scholars for any of their research projects or preparations for their board exams